Beekeeper Administrative Core for COSMIIC HORNET

The primary goal of this COSMIIC HORNET project is to enable the research field to not only have
access to new implantable technology, but also, where possible, to establish the ability to modify and innovate
around that implantable technology. In order to achieve this goal, it is absolutely necessary that the COSMIIC
HORNET project is directly applicable to the bioelectronic research community and provides the appropriate
resources. To achieve this, we have formed a team of over 30 experts in neural interface technologies and
their clinical applications. This “Beekeeper Team” will provide administrative oversight for the project.
A key feature of our Beekeeper core is that it has broad representation of the spectrum of clinical
applications for our implantable open source neuromodulation technology. The long-term objective of this
project is widespread use of the COSMIIC modules to develop new medical treatments for a wide range of
applications. This requires a focus on early dissemination and sustainability. The administration of this project
will therefore have the following three specific aims:
Aim 1) Ensure the widespread utility of the novel modules. The beekeepers will provide feedback on
novel designs early in the design process to ensure that the device specifications and modes of operation will
serve a wide community of users. In conjunction with an external advisory board, the administrative team will
also monitor progress on the scheduled project milestones.
Aim 2) Evaluate the distributed resources for completeness and safe ethical use. The COSMIIC
HORNET modules will be designed for use by research teams with strong engineering expertise, who must
have a thorough understanding of the devices they will use. The Beekeeper team will evaluate design and
regulatory documentation prior to distribution to the public
Aim 3) Create a community of early adopters who can serve as a resource for others. Each beekeeper
has a personal interest in using this technology for their own research. During the course of this project, they
will lay the groundwork for that use at the end of three years through FDA communications and grant
applications. Each of the application represented by the beekeepers has a larger community of scientists who
may benefit from using these devices. Beekeepers will serve as an ambassador for these novel devices within
that community and we will also support and incorporate additional users who wish to become early adopters.
At the end of this project, the existing modules already in human use will be fully open-sourced
including all regulatory communications. Novel designs will be complete, and well documented. There will also
be an online community of users at a variety of stages of adoption.